Characterizing the evolution of Subjective Cognitive Decline in preclinical Alzheimer's disease

Project Summary
As Alzheimer's disease (AD) treatment strategies increasingly focus on prevention at the preclinical stage, a
corresponding effort to improve detection of early changes in cognitive function is urgently needed. Subjective
Cognitive Decline (SCD) provides a unique opportunity to identify emerging cognitive symptoms from the
person's own perspective that can complement neuropsychological assessment at the preclinical stage.
Furthermore, SCD has direct applications for AD prevention trials seeking to demonstrate treatment effects
that impact study participants' daily lives. We propose to recruit a new cohort of SCD individuals who report a
concern for recent, persistent changes in cognitive functioning. Individuals will be recruited from both the
community and the memory disorders clinics (n=100) and will be followed over the course of 3 years.
Specifically, we will capture high frequency SCD report (i.e., quarterly) that can be administered unsupervised
via personal electronic device (e.g., computer, smart phone, tablet). In this way, participants will be able to
complete assessments at-home, rather than coming to the clinic. SCD trajectories will be associated with other
markers of disease severity, including in vivo AD biomarkers longitudinally, amyloid (Pittsburgh Compound B-
PET) and tau (Flortaucipir-PET) and objective cognitive decline. The information gleaned from these
complementary methods will improve our ability to identify high risk participants more likely to decline and to
track clinically meaningful response to treatment.

Public health relevance
Project Narrative Subjective cognitive symptoms are common in older adults, but increasing evidence suggests that for a subset of individuals, noticing a change in memory may be an early sign of underlying Alzheimer's disease (AD). The goal of the proposed study is to track subjective cognitive symptoms over time, including an electronic at-home assessment that can be completed on a more frequent basis than questionnaires given at the clinic. The pattern of subjective cognitive symptoms will be compared with in vivo markers of AD pathology; amyloid and tau, and decline in performance on standardized cognitive measures.